Cancer Biology Training Grant

[unreadable] DESCRIPTION (provided by applicant): This predoctoral and postdoctoral training program emphasizes bench to bedside research encompassing state-of-the-art areas of cancer research. Along with training in the fundamentals of cancer research and sound scientific theory, students will be trained in fundamental drug discovery using high throughput chemical and genetic screens to define cellular networks, signal transduction pathways, DNA damage and repair responses, and nanomedicine-targeted therapeutic drug delivery using cell and animal molecular imaging. The problem of cancer in the 21st century remains a national priority, and as such, offers a substantive long-term career opportunity for the training of predoctoral and postdoctoral students. The goals of our training program are to (a) train top-quality scientists capable of conducting independent cancer research; (b) foster the intellectual, technical, and communication skills required to succeed in the academic or industrial arenas of today and in the future; and (c) provide an understanding of the basic, public health, and clinical problems of human cancer. The ability of this training grant to bridge an existing outstanding foundation of Faculty in Basic Science with newly developed Cancer Biology and Therapy Programs in the Simmons Comprehensive Cancer Center, distinguishes it from a standardized general graduate and post- graduate educational program. We have 30 committed Faculty Trainers representing 16 different Departments and Centers at UT Southwestern. We have assembled a dedicated group of leaders that will constitute the Steering Committee of the Training Program, along with Administrative Support and both intellectual and financial support from the Director of the Cancer Center. We have an integrated plan for the proposed Cancer Training Program for both predoctoral and postdoctoral trainees that details all key steps in cancer education and training, including biomedical ethics and the responsible conduct of science. We have a program specific plan for recruiting a geographically broad range of predoctoral and postdoctoral applicants as well as underrepresented minorities trainees. We have expanded and implemented our cancer didactic and journal oriented courses, both basic and translational as well as a monthly cancer center trainee meeting. This Cancer Biology Training Program will serve the needs of all North Texas, an area where no current cancer research training is present. [unreadable] [unreadable] [unreadable] [unreadable]